Development of an AI Assistant for Individuals with Low Vision and Blindness

The National Eye Institute estimates that in the United States there are presently over 1 million legally
blind people and this number will increase to about 4 million by 2050. According to the VA Office of Blind
Rehabilitation Services, there are approximately 130,000 US Veterans who are legally blind and more than one
million who have lost the ability to perform daily tasks because of low vision. Some of these people can be
helped by relatively simple and inexpensive devices such as magnifiers and canes. However, with more severe
vision loss, people are likely to experience loss of independence and reduced quality of life. Blindness has a
major impact on Veterans and others, as evidenced by the fact that over 70% of working-age people with
significant visual impairment are unemployed.
While there are causes of blindness that can be readily corrected, in many cases there is no effective
treatment. One solution is to restore vision by surgically placing electrodes in the retina or visual cortex and
electrically stimulating the brain based on the light level recorded by a head-mounted camera. Systems of this
type are being developed and they have great potential. However, there are downsides to the implanted
systems that include the risks of surgery, high cost, and a form of vision that is severely limited compared to
normal perception. There is also a wide array of devices and smartphone apps that perform specialized
functions (text readers, obstacle detectors, color identifiers).
The goal of the proposed research is to develop and test a new type of visual assistive device, named
AEyes, for individuals with blindness and low vision. It takes advantage of recent advances in artificial
intelligence including computer vision, machine learning, optical character recognition, speech recognition, and
3D sound rendering to give the user the ability to recognize, localize, and interact with objects and people in
their vicinity. In other words, the AI technology that can benefit people with low vision already exists and it will
be implemented in a device tailored to the needs of people with visual disorders. The system will be intuitive
and easy to learn and interact with as it understands spoken instructions and it speaks to the user. AEyes has
been developed based on a needs-analysis and feedback from focus groups, one-on-one interviews, and
prototype tests with Veterans conducted at the VA Providence Healthcare System.
Aim 1 concerns device development. The system architecture and algorithms are largely implemented
and functional, but a range of refinements to the software and the integration of separate functional modules
into the overall system are needed. These improvements include upgrading to a higher resolution camera,
retraining the recognition neural network, and integrating the face recognition, hand tracking, and voice
recognition modules into the central architecture.
Aim 2 consists of device tests that will be conducted with subjects having a range of low vision
conditions that include no light sense, retinitis pigmentosa, glaucoma, macular degeneration, and diabetic
retinopathy. The tests to be conducted include the ability of a user to recognize and localize people, reach for
and grasp objects, read text on handheld paper, computer displays, and signs, and train the system to
recognize new people. Comparing performance with residual vision alone and with the addition of AEyes will
establish the device’s effectiveness as a visual assistant and indicate where improvements are needed.

Public health relevance
There are over 1 million blind people in the United States and the National Eye Institute estimates this number will increase to about 4 million by 2050. According to the VA Office of Blind Rehabilitation Services, there are approximately 130,000 US Veterans who are legally blind and more than one million who have lost the ability to perform daily tasks because of low vision. This project develops and tests a new type of AI-supported visual assistive device, named AEyes, for individuals with blindness and low vision. It takes advantage of recent advances in artificial intelligence including computer vision, machine learning, optical character recognition, speech recognition, and 3D sound rendering to give the user the ability to recognize, locate, and interact with objects and people in their vicinity. AEyes will significantly increase the confidence and independence of its users.